P&F Projects

PROJECT SUMMARY / ABSTRACT
Pilot projects within the UAB P30 Center contribute to multidisciplinary research on our campus,
enhance faculty development, extensively utilize Scientific Cores, and integrate well with the
global research themes of the UAB Center. A strong and well-supported Pilot and Feasibility
mechanism has allowed the Center to address new research priorities and expand its scientific
purview. The goals of the P30 Pilot and Feasibility Component are delineated through four
Specific Aims. First, the Pilot Program identifies and supports new research projects of
outstanding quality and innovation. Projects typically last one to two years each, are concordant
with the overall objectives of the UAB P30, and are intended to result in further grant support
from NIH, Cystic Fibrosis (CF) Foundation, or other funding agencies. Second, the Pilot
Program supports promising junior faculty in career development through funding of outstanding
pilot research. The Center Enrichment Program, strong mentoring within the CF Center, a
robust Enrichment program, and extensive training resources available at UAB through the
Center for Clinical and Translational Science (UAB's NIH-funded CTSA research program) are
also employed toward this end. Third, the Pilot Program augments the breadth and quality of CF
research by funding innovative projects from established researchers with valuable expertise
who are new to CF research, or alternatively from established CF investigators who want to test
new high-impact hypotheses. And fourth, the Pilot Program provides an administrative
framework for review and oversight of Pilot and Feasibility Studies. This includes broad
solicitation and rigorous peer review of Pilot applications, recommendations regarding 2nd-year
funding of Pilots to the Internal Advisory Committee, assistance and mentoring to pilot PIs, and
record-keeping with regard to publication and grant outcomes that result from pilot funding to
provide evidence for continuous process improvement. Overall, the Pilot Program has had a
important impact on CF research at UAB, has been very successful in assisting multiple faculty
early in their careers to successfully obtain extramural funding for CF research, and has
enlarged our Research Base in new innovative directions.